Geographic and Racial Disparities in Mammography Screening and Barriers to Receiving Care

PROJECT SUMMARY
This K01 proposal entitled “Geographic and Racial Disparities in Mammography Screening and Barriers to
Receiving Care” describes the career development and research plan that will be instrumental in the
development of Dr. Justin Xavier Moore’s transition into an independent investigator in the field of breast
cancer disparity and community-based participatory research. Dr. Moore has a background in epidemiology
and cancer prevention and control that includes training in quantitative methods, research design, geospatial
analysis, and social epidemiology. However, this grant will provide Dr. Moore with additional needed training in
Bayesian methodology and inference, qualitative and mixed-methods, health communication, participant
recruitment, and community-participatory research through a combination of courses, independent studies with
hands on focus, and mentoring. Dr. Moore’s interdisciplinary mentors include researchers with achievements in
breast cancer disparities research, cancer health communication through community-based participatory
research, qualitative and mixed methods approaches as indicated through their multiply funded NIH awards.
Further, their expertise will provide the necessary support for the career development and research activities of
the study proposed in this application by Dr. Moore.
The proposed research will provide valuable insight to the field of breast cancer disparities and address key
public health questions of relevance to racial and geographic disparities in breast cancer using innovative
analytical methods. It will combine Dr. Moore’s expertise in spatial and cancer epidemiology with the mentors’
expertise in large intervention studies on breast cancer, health communication and community-based
participatory research, and mixed-methods analysis to understand the individual, interpersonal, community
facilitators of mammography screening among minority (Hispanic and Black) women living in the highest risk
communities of the United States. The research includes specific aims that be will achieved using
interdisciplinary research methods including Bayesian methodology for small-area estimates of mammography
screening, semi-structured interviews, and survey research among those recruited within the pilot study. The
aims include: (1) identifying areas of low mammography screening among Black and Hispanic women using
novel small-area estimation; 2) quantifying a novel index of high-risk counties for breast cancer among Blacks
and Hispanics, and 3) performing a pilot study among Black and Hispanic women, stratified among the novel
index, to understand the personal, interpersonal, and community barriers on intentions to receiving
mammography screening. Through the proposed research the investigator will understand culturally specific
barriers and develop a strong rapport within high-risk communities using a community-based approach that will
provide a foundation to develop a larger longitudinal study with sustainable interventions.

Public health relevance
PROJECT NARRATIVE Racial/ethnic minorities are disproportionately affected by breast cancer outcomes as Black and Hispanic women are 20% more likely than White women to be diagnosed with advanced stage breast cancer; and have up to 70% and 14% increased risk of death, respectively. This K01 project aims to identify areas of low mammography screening, and to elucidate the racial/ethnic specific barriers on the uptake of adequate mammography screening for Black and Hispanic women within the defined high-risk areas. The long-term goal of this research trajectory is to contribute to the reduction of racial and geographic disparities in breast cancer outcomes.